Admin Core

The primary objective of the Administrative (Admin) Core is to integrate, coordinate, and manage components of all components of ZAMBAMA (i.e., the two research projects and two additional cores). The Admin core is also responsible for all budgetary (e.g., processing payments, ordering supplies) and regulatory activities (e.g., communication with NIAAA, coordination of Data Safety Monitoring Board activities, IRB activity, tracking adverse events), monitoring and managing overall progress, and promoting coordination and collaboration among investigators within and outside of the program.
The Specific Aims of the Admin core are the following: 1) Synchronize scientific aims and foster shared scientific progress between the projects; 2) Manage overarching program business and regulatory requirements; and 3) Enhance collaboration among investigators within and outside of the program. Through this Program Project Grant, we will leverage the infrastructure of our cores, research projects, and infrastructure to achieve our overall aims to 1) better characterize the overlapping burden of mental illness and substance use comorbidity among PWH with unhealthy alcohol use, 2) evaluate whether and how comorbidity impacts alcohol reduction intervention outcomes, 3) determine the effectiveness of a transdiagnostic cognitive behavioral therapy, and 4) examine implementation factors related to integrated delivery of alcohol reduction interventions to PWH at front-line HIV clinics. The proposed work is integrated and synergistic, and the Admin Core function to leverage this program’s infrastructure, collaborative relationships, and multidisciplinary expertise to achieve goals that are greater than the sum of its parts.

Public health relevance
The goals of the ZAMBAMA Administrative Core are to 1) Synchronize scientific aims and foster shared scientific progress between the projects; 2) Manage overarching program business and regulatory requirements; and 3) Enhance collaboration among investigators within and outside of the program. Through these aims the core will ensure that the activities of Projects 1 and 2 are harmonized and efficiently supported by the other cores (the Common Elements Treatment Approach [CETA] and Methods and Analysis [MAC] Cores). The Admin Core will optimize the scientific contributions of this Program Project Grant, ultimately advancing the treatment of HIV, unhealthy alcohol use, and mental health comorbidities among people with HIV in rural and not yet reached communities.